CLARITHROMYCIN VS RIFABUTIN VS BOTH TO PREVENT MYCOBACTERIUM AVIUM IN HIV ADULTS

Multicenter trial comparing the efficacy of clarithromycin alone versus rifabutin alone versus clarithromycin plus rifabutin for the prevention or delay of Mycobacterium avium or disseminated Mycobacterium avium disease.